MOLECULAR BIOLOGY OF OUTER RETINA-SPECIFIC PROTEINS

Retinal pigment epithelial (RPE) cells and the photoreceptor (PR) cells are functionally and developmentally closely integrated. During development of the outer retina in rat, the determinant recognized by the RPE-specific monoclonal antibody RPE-9 is first expressed at post-natal day 3 whereas the PR outer segments (OS) appear at day 5. The OS first appears where RPE cells are already expressing their determinant. RPE-9 recognizes a 67-kDa protein specific to the RPE. This protein is found in mammalian and avian RPE. A membrane-associated protein, it is probably non-glycosylated. We have begun to screen a bovine RPE cDNA library for a cDNA for this protein. We have subcloned DNA fragments corresponding to the first two repeats of bovine IRBP into a bacterial expression vector. IRBP is involved in the transport of retinoids, a functional relationship between the RPE and the PR. The resultant expressed protein fragments will be tested for their ligand-binding and immunological properties.